Texas Animal Food Product Testing and Food Defense for Microbiology, Chemistry, and Radiochemistry.

OVERALL RESEARCH PLAN, title: Texas Animal Food Product Surveillance, Food Defense,
Method Development and Capacity Increase for Microbiology, Chemistry and Radiochemistry
Abstract: The overall aim of the Office of the Texas State Chemist (OTSC) submission to the
Laboratory Flexible Funding Model (LFFM) program is to support the United States (US)
integrated food safety system. Specifically, this program focuses on the disciplines of
microbiology, chemistry and radiochemistry in the animal food product testing and food defense
tracks, whole genome sequencing maintenance, method development/validation and
capability/capacity development. OTSC commits to utilize and expand it capabilities in the three
target disciplines: microbiology, chemistry and radiochemistry and continue ISO 17025:2017
accreditation. OTSC will follow the LFFM Sample Guide for planning, collecting, analyzing,
reporting, and follow up on LFFM samples and engage the Texas Feed and Fertilizer Control
Service (FFCS) in all sample collection and compliance activities. OTSC agrees to accept and
analyze samples collected by FDA or other states for all three discipline and implement GFP-
tagged control strains for Salmonella, Listeria monocytogenes, and E. coli, conduct non-target
screening, and perform FERN food defense methods CHE-0008, CHE-0006 and EMA 4.7.
OTSC possess the ability to analyze human and animal food for the detection of alpha-, beta-,
and gamma-emitting radionuclides. The OTSC laboratory is ISO 17025:2017 accredited to
perform microbiology, chemistry and radiochemistry animal food surveillance and food defense.
OTSC is comprised of a laboratory which is titled the Agriculture Analytical Service (AAS) and a
state regulatory program officially titled the Texas Feed and Fertilizer Control Service (FFCS),
hereafter referred to as the Service. OTSC is funded through inspection fees as established in
the Texas Commercial Feed Control Act (Texas Agriculture Code Chapter 141 and no LFFM
funds are used to displace state appropriated funding. The headquarters of OTSC are located
on the Texas A&M University College Station campus, which includes a fully equipped
laboratory to perform all aspects of the LFFM project. Through participating in this program,
OTSC will enhance the capacity and capabilities of the Texas animal food testing laboratory to
support the US integrated food safety system. OTSC has a current 20.88 form and will follow
version 2 of the LFFM sampling guide.

Public health relevance
OVERALL RESEARCH PLAN, title: Texas Animal Food Product Surveillance, Food Defense, Method Development and Capacity Increase for Microbiology, Chemistry and Radiochemistry Narrative: The overall aim of the Office of the Texas State Chemist (OTSC) submission to the Laboratory Flexible Funding Model (LFFM) program is to support the United States (US) integrated food safety system. Specifically, this program focuses on the disciplines of microbiology, chemistry and radiochemistry in the animal food product testing and food defense tracks, whole genome sequencing maintenance, method development/validation and capability/capacity development.